Physiology Core

Abstract
The Physiology Core provides a series of graded technologies and expertise to investigators who wish to
address fundamental questions about transport processes that occur in the tubular structures of the nephron
and other relevant systems. To gain understanding of biological processes that mediate kidney function in
health and disease states, in light of the phenotypic diversity and functional complexity of this organ, the use of
strategies that allow specific nephron segments/cells/proteins to be studied in isolation under defined
conditions is required. The Core, through its three Subcores, offers expertise and state-of-the-art technologies
for studying the function and regulation of transport and other membrane resident proteins with progressive
degrees of complexity from single molecules to model systems to native epithelia. The Single Tubule and
Microperfusion Subcore provides tools and technologies to study the function and expression of transport
proteins and associated regulatory pathways in single nephron segments isolated from small mammals and
kidney organoids. The Electrophysiology Subcore provides expertise and a toolbox of electrophysiological
approaches to study the function and regulation of transport proteins at the molecular and cellular levels in
model systems and native epithelia. The Live-Cell Imaging Subcore offers imaging tools and technologies to
assess ion transport, changes in membrane potential, cellular volume, intracellular mediators, and signaling
molecules in immortalized cells and native preparations using chemical and genetically encoded fluorescent
sensors. The Core will apply a multipronged approach and collaborate with the O’Brien Consortium to share
specialized resources and technologies throughout the kidney research community, to lower the barrier to
entry for early-stage investigators and researchers new to the kidney field, and to advance kidney research
and discovery nationwide.